COMPARISON BETWEEN ENDOCARDIAL LASER PHOTOABLATION AND ELECTRODE SHOCK ABLATION

Comparisons were made of the morphological characteristics of endocardial lesions produced by transcatheter delivery of either laser irradiation or electrical shock in closed-chest anesthetized dogs. The results obtained show that transcatheter laser photoablation can produce controlled endocardial lesions with less energy and fewer deleterious effects than transcatheter electrode shock.